Targetomes of infection-specific small RNAs of Bartonella bacilliformis

Bartonella bacilliformis (Bb) is a highly-virulent, sand fly-vectored bacterium responsible for Carrión’s disease in
humans. This chronically-neglected tropical disease is re-emerging in endemic regions of the Andes and
expanding into non-endemic areas (i.e., lower altitudes and more diverse habitats) of Peru, Ecuador and
Colombia. An estimated two million people in an area of ~145,000 square-km in South America are at risk of
infection by Bb, and incidence rates of 12.7 / 100 person-years have been reported in endemic regions. Bb
infections are potentially life-threatening, with fatality rates as high as 88% if left untreated, and ~10% fatality
rates following antimicrobial intervention. In non-endemic regions, Carrión’s disease manifests as an acute
febrile illness with an ~80% reduction in erythrocyte hematocrit (Oroya fever), whereas in endemic regions,
angiomatous skin lesions (verruga peruana) and chronic bacteremia are most common, effectively creating a
human reservoir for the pathogen. Our long-term goal is to elucidate how Bb regulates expression of gene
products required to survive in the sand fly vector and human host, with overarching objectives of: a)
generating information that can be applied to the eventual eradication of Carrión's disease and b) providing a
model of virulence gene regulation in Bartonella and other arthropod-vectored, pathogenic bacteria. Our
discovery of 24 human-infection-specific sRNAs and 8 sand fly-specific sRNAs (from a total of 160 Bb sRNAs
identified) suggests that sRNAs are used to post-transcriptionally control translation in the host and vector,
respectively. We hypothesize that human-infection-specific, trans-acting sRNAs regulate transcripts for gene
products that are required for Bb survival in humans. The hypothesis will be addressed by two specific aims. In
aim 1, we will characterize the mRNA targetomes of three prominent sRNAs through crosslink-Seq analysis of
live Bb. In aim 2, we will confirm and analyze the identified sRNA-mRNA interactions using EMSAs and reporter
constructs. Results of the study will provide a foundational analysis of the regulons for three dominant, infection-
specific sRNAs of Bb. More broadly, the research will also establish a model for elucidating sRNA regulons in
arthropod-vectored bacterial pathogens.

Public health relevance
Bartonella bacilliformis is the sand fly-vectored, bacterial agent of Carrións disease in humans; an emerging and neglected tropical disease that threatens nearly two million people in ~145,000 square km of South America. The proposed research will characterize the mRNA targets of three established, human-infection-specific small RNAs (sRNAs) of B. bacilliformis. The results will provide an essential foundation for elucidating sRNA-mediated regulation in this highly-virulent arthropod-borne pathogen, and since each sRNA is upregulated during infection, they could conceivably be targeted in the future to inhibit pathogenesis.